Innate mechanisms for virus-induced diabetes

? DESCRIPTION (provided by applicant): Viral infection has been associated with the development of type 1 diabetes (T1D) but a causal role for viruses remains unproven. Studies in animals have been problematic because of differences in host species- specific susceptibility and immune responses to candidate viral pathogens such as coxsackie B virus (CVB). In order to better evaluate the impact of viruses in causing human T1D, we developed a viral infection model in immunodeficient mice bearing human islet grafts that are crucial for glycemic control. In this model, infection with CVB led to diabetes in nearly half of all infected animals. Human islet grafts from CVB4-infected mice contained viral RNA, expressed viral protein, and had reduced insulin compared to grafts from mock-infected mice. Gene expression profiles from the human grafts also revealed induction of signature genes, such as multiple interferon stimulated genes. In this platform CVB4 infects human beta cells that subsequently become severely dysfunctional with diminished insulin production, leading to diabetes. In the proposed study, we will examine: 1) whether the functional destruction of beta cells is due to a deleterious innate response, direct destruction by virus, or a combination of the two, and 2) what are mechanisms of beta cell dysfunction and/or death. Further investigation of viral infection of human islets using combined in vitro and in vivo approaches will lead to a clearer understanding of the innate factors that contribute to virus-induced T1D. These studies will identify and characterize mutant viruses that are not diabetogenic and thus potential vaccine candidates.

Public health relevance
PUBLIC HEALTH RELEVANCE: Type 1 diabetes (T1D) is an immune mediated disease driven by both genetic and environmental factors, including infection with viruses. In this research study, we will focus on a particular virus can cause T1D by using the virus to infect living human tissues that have been transplanted into a mouse to keep them alive long term. We will study what viral and human genetic factors are essential in the development of virus-mediated diabetes by altering both the virus and the human tissues. Specific genetic variations that are "pro-diabetic" and "anti-diabetic" will be identified so that and fundamentals on T1D development will be defined and vaccine strategies can be developed.